HIV-1 Tat genetic variation impacts NeuroAIDS

Project Abstract/Summary
The viral load can be controlled in the periphery of HIV-1-infected patients through consistent use of antiretroviral
therapy (ART). Despite this, over 50% of HIV-infected patients are predicted to suffer from HIV-associated
neurocognitive impairment (NCI). Although the pathogenesis of NCI is incompletely understood, HIV-1
transactivator of transcription (Tat) has been shown to be capable of being secreted from infected cells, and
once extracellular within the central nervous system (CNS) it will induce neuronal dysregulation. Early in the
infection, HIV-1 has been shown to establish a reservoir in the brain, either by entering as infected perivascular
macrophages or infecting resident microglia, prior to the patient receiving ART. ART does not affect the
production of Tat, which is continually made in these cells, leading to quantifiable levels of Tat in the absence of
detectable viral load. Tat sequence composition varies within and between individuals due to HIV-1’s error-prone
reverse transcriptase and host factors such as APOBEC3G. In the previous 5 years, we have shown that this
variation is associated with NCI, as shown by our studies comparing the HIV-1 Tat protein sequence composition
from impaired and non-impaired patients within the Drexel Medicine CNS AIDS Research and Eradication Study
(CARES) Cohort. Residues associated with NCI included 59P, 74H, and 12K, while 36V, 40T, 63E, and 23T
were associated with non-impairment. Effects of Tat variation can be further exemplified by Tat’s interaction with
the NMDA receptor (NMDAR). This interaction can be weakened when Tat undergoes a C31S mutation, as
shown in HIV-1 subtype C infections. Our preliminary data has shown that Tat genetic variants within the CARES
Cohort have different predicted interaction profiles with GRIN2A, a subunit of NMDAR. Although the Tat-NMDAR
interaction has been shown to be an established driver of HAND, it may not be the only factor involved in NCI in
neuroHIV. Given this, we hypothesize that HIV-1 Tat genetic variation may cause differential secretion of Tat
and/or affect Tat’s binding to molecular targets leading to neuronal dysfunction that underlies NCI in neuroHIV.
To investigate this, we propose three Aims. Aim 1 will determine if amino acid variations in Tat associated with
NCI via peripheral blood sampling correlates to that found in the CNS and/or intact provirus. Aim 2 will explore
the impact of HIV-1 Tat genetic variation on protein-protein interactions that contribute to HAND pathogenesis.
Aim 3 will assess the contribution of HIV-1 Tat variants to NCI using an in vivo model of Tat-induced
neuropathogenesis. Overall, these studies will contribute to defining the mechanism of how HIV-1 Tat
polymorphisms alter interactions with neurons and ultimately affect CNS function. Successful completion of the
proposed project will result in a better understanding of the etiology of HAND, potential development of diagnostic
assay for HAND, and identification of novel Tat-mediated targets for treating NCI.

Public health relevance
Project Narrative This proposal will build upon data from the previous funding period to understand how genetic variation in the viral accessory protein Tat affects its function and hence neuroHIV. Using complimentary in silico, in vitro, in vivo and ex vivo assays, we propose to delineate the mechanism by which Tat promotes neurotoxicity and neurocognitive impairment. Successful completion of the proposal will have implications in developing novel therapeutics to treat neurocognitive impairment and genetic diagnostic assays.